Statistical methods for longitudinal integrated mechanistic modeling of multiview data

Abstract
In longitudinal neuroimaging studies, modeling within-subject variation across time offers insights about time-
dependent effects and causal relationships in brain changes related to neurodevelopment, neurodegeneration, or
disease progression. Uncovering and quantifying the multi-way relationship across modalities, including environ-
mental, *omics, imaging, and neurocognitive data, will help better understand the mechanisms behind complex
diseases, such as the impact of substance abuse on neurodevelopment and Alzheimer's Disease. Considering
genetic, demographic, and phenotypic traits, it is crucial to characterize disease heterogeneity, such as sex-
related differences, for precision medicine. Though methods to perform longitudinal and path analysis of univari-
ate data can be applied to individual data elements, limited methods are available directly for data with structured
constraints and integrated analysis of large datasets. The long-term goal of this proposal is to develop novel
statistical methodologies to analyze longitudinal high-dimensional data with mathematical constraints and novel
generalized path analysis methodologies to integrate complex data collected from multiple sources, with appli-
cation to the study of neurodevelopment/neurodegeneration and related mental disorders. The overall objective
is to elucidate longitudinal effects on brain structure and function, to characterize population heterogeneity, to
understand the role of different modalities and mechanisms, and to provide guidance on personalized early
prevention/intervention strategies. The challenges of longitudinal integrated mechanistic modeling of multiview
data include (i) longitudinal modeling of variables with complex structure (e.g. positive deﬁnite matrices), (ii)
high dimensionality and heterogeneity, (iii) delineation of multiple pathways, and (iv) development of large-scale
and computationally efﬁcient algorithms. To address these, three speciﬁc aims are proposed: (1) develop novel
regression frameworks for multiple longitudinal, high-dimensional covariance matrix outcomes with predictors
across modalities; (2) develop big-data path analysis with longitudinal, high-dimensional, complex variables;
(3) develop statistical methodologies to characterize individual growth trajectories of complex variables. Aim 1
introduces longitudinal models with covariance matrices as the outcome to investigate changes in data struc-
ture and/or characteristics at a network level. Aim 2 innovates path regularization and integrated optimization
criteria for high-dimensional structured data to identify markers and search for causal pathways under longitudi-
nal settings. Aim 3 develops methodologies to guide personalized prevention/intervention strategies. To foster
dissemination, repeatability, reproducibility, and replicability of scientiﬁc ﬁndings, open-source software will be
developed. The proposed research is innovative because it proposes methodologies to perform longitudinal and
path analysis for high-dimensional data with complex and speciﬁc structures collected from multiple domains.
The proposed research is signiﬁcant because it will enrich the understanding of the human brain and guide
practitioners to promote well-being in adolescent and elderly populations.

Public health relevance
Project Narrative The proposed research aims to develop novel statistical methodologies for longitudinal integrated mechanistic modeling of multiview data, including environmental, *omics, imaging, and neurocognitive data. The proposed methodologies, developed and applied to alcohol & neurodevelopmental and Alzheimer's disease research, are expected to elucidate longitudinal variations in brain structure and function, to characterize population hetero- geneity, to enhance understanding of disease pathology, to help identify biomarkers, and to provide guidance on personalized early prevention/intervention strategies to promote well-being in adolescent and elderly popula- tion. Therefore, the proposed research will seek fundamental knowledge in integrated analysis for improving our understanding of neurodevelopmental/neurodegenerative trajectories and related mental disorders.